IRACDA at the University of Michigan

The University of Michigan (UM) has a superb history of training postdoctoral fellows and is committed to developing a highly qualified pipeline of future teachers and students pursuing Science, Technology, Engineering or Mathematics (STEM). With this in mind, UM partners with two local colleges, Henry Ford College (HFC) and Eastern Michigan University (EMU), to develop the Michigan IRACDA (Institutional Research and Academic Career Development Award) Program to develop future scientist educators. HFC and EMU each have 18,000-20,000 students, and both colleges provide numerous courses for participation by our scholars and teaching mentors with outstanding teaching records and strong commitments to sharing their expertise. The proposed four-year program for each trainee scholar involves an initial 3 years of 75% research training by UM research mentors with excellent records of mentorship and funding. The participating research mentors span the University community and include a combined record of training >400 current and past trainees and nearly $15M in current funding. The remaining 25% training time during the first 3 years consists of training in teaching and professional development. Training in teaching involves extensive classroom experiences at HFC and EMU, participation in outstanding programs provided by the renowned UM Center for Learning and Teaching (CRLT) and culminating in a “capstone” experience chosen by each scholar. Capstone experiences include serving as instructor of record for an entire course, generation of new curricular materials, or participation in education research. The 4th year of training will be covered by the research mentors providing full time in the laboratory to allow the scholars to complete research projects, publish papers, carry out some teaching and work towards securing a faculty position. For this renewal application, our program objectives are to (1) promote independent, innovative, and rigorous scholarship, team-science, and research discovery; (2) engage our Fellows in unique teaching experiences each year with expert teaching mentors and formal pedagogical training; (3) provide extensive, individualized mentoring using IDPs, mentoring plans, trained faculty mentors, and both peer-to-peer and alumni networking; (4) deliver a range of professional development opportunities, including training in RCR, and Rigor & Reproducibility; and (5) provide pedagogical and professional development opportunities for teaching mentors and inform students at HFC and EMU about STEM education, research, and careers. Unique features of our Program include the outstanding record of the research and teaching mentors, a focus on students at community colleges and primarily undergraduate institutions (PUI) where we anticipate a huge impact on the trajectory of the students, full engagement of the renowned UM CRLT, a robust scholar and Program evaluation process, and strong institutional support. We are confident our program will continue our demonstrated success in preparing a new generation of scientist-educators to be highly effective and successful faculty members and mentors, and that we will inspire an up-and-coming cohort of students to pursue science and engineering careers.

Public health relevance
This proposal will extend our existing IRACDA Program at the University of Michigan. Through partnerships with Henry Ford College and Eastern Michigan University, our IRACDA program trains postdoctoral fellows in both research and teaching with the goal of developing a pool of biomedical scientists who are well-prepared for independent academic careers in STEM fields.